Hopkins Center to Promote resilience in persons and families living with multiple chronic conditions (the PROMOTE Center)

Pilot Administrative Core Abstract
The Pilot Administrative Core of the PROMOTE center will support a paradigm shift from provider-centric,
disease-specific biomedical approaches to person-centered, community focused methods to address multiple
chronic conditions. The Center investigators will develop and evaluate innovative, theory-driven intervention
strategies using person-centered bio behavioral approaches and measures to generate new knowledge that
informs policy and practice. Rigorous, multi-method approaches to intervention development, testing, and
dissemination will involve interdisciplinary scientists partnering with target populations and other key
stakeholders to understand and address multiple, inter-related factors (environmental and individual) critical to
individual and family resilience. Unparalleled interdisciplinary resources and expertise available through the
Johns Hopkins Institute for Clinical and Translation Research; the JHSON Office for Science and Innovation
and Biostatistics and Methods Core; numerous Centers and Institutes across our institution; as well as external
collaborations will be mobilized by the Core to drive scientific advances in resilience and multiple chronic
conditions as well as to build new research teams to drive it. The specific aims of the Pilot Administrative Core are
to: 1. Support the development and implementation of rigorous, community-informed research designs and methods for
pilot projects that advance interdisciplinary science of multiple chronic conditions. 1.1 Establish multiple, regular
forums to promote ideation, innovation, and interdisciplinary exchange to advance the science of multiple chronic
conditions. 1.2 Provide consultation, preliminary data analysis, and design consultation of P30 pilot project
proposals and grants.1.3 Provide focused methods and analysis support and cross learning for on-going
projects through chalk-talks by P30 projects with experienced methodologists, statisticians, and all pilot project
directors. 2. Provide technical support for use of common data elements, data management and sharing across pilot
projects and NINR Centers 2.1 Provide support for P30 projects to meaningfully integrate common measures
into their projects and provide the infrastructure for a common measures data warehouse to merge data across
all of the P30 projects.2.2 Facilitate research design and analysis of the pooled data across pilot projects and
other P20/P30 sites to answer research questions integral to the P30 Center's mission. 2.3 Facilitate a data
management group to ensure data integrity across all projects.3. Facilitate the development and sustainability of
productive interdisciplinary research teams to advance the science of multiple chronic conditions including facilitating
cross center scientific exchange to advance evidence on resilience and chronic conditions 4. Administer the pilot project
program. This will include organizing annual calls for proposals of pilot intervention studies, organizing and administering
pre-pilot funding. Procedures will be implemented to evaluate the pilot proposals on their progress, scientific merit and
potential to lead to fundable research programs after the successful execution of the pilot projects.